Functional and molecular consequences of SF3B1 mutations in human hematopoietic stem cells

ABSTRACT
The surprising discovery that RNA splicing alterations induced by recurrent and common change-of-function
mutations in the spliceosome can perturb hematopoiesis and lead to disease has raised a number of fundamental
questions. SF3B1 mutations are found ~30% of patients with myelodysplastic syndromes (MDS) and are
common disease-initiating events that first arise in hematopoietic stem cells (HSCs) in premalignant clonal
hematopoiesis, or CHIP. The finding of SF3B1 mutations in CHIP suggests that these mutations confer a clonal
fitness advantage to HSCs. However, how SF3B1 mutations dysregulate HSC function to promote clonal
expansion and subsequent MDS development has not been established. We lack an understanding of how these
mutations “re-wire” RNA splicing in HSCs, which mis-spliced genes are critical for promoting clonal expansion
and impaired differentiation of mutant stem cells, and how to target pathogenic mis-splicing while sparing
alternative splicing that is essential for normal HSC function.
Here, we propose to gain a fundamental understanding of how SF3B1 mutations promote CHIP and MDS and
use this knowledge to develop new therapeutic approaches. Our team consists of a stem cell biologist with
expertise in hematologic disease modeling (Doulatov), a basic scientist with expertise in RNA splicing and
functional genomics (Bradley), and a physician-scientist with expertise in MDS pathophysiology (Abkowitz). In
preliminary studies, we leveraged precise gene editing in human HSCs to define the molecular and functional
RNA splicing alterations induced by mutant SF3B1 in the HSC context. These experiments uncovered novel
HSC-specific mis-spliced isoforms, implicating an altered response to inflammatory signaling in pathophysiology;
showed that SF3B1-mutant human HSCs display robust in vivo reconstitution in humanized mice, including a
competitive advantage over their wild-type counterparts; and identified checkpoint kinase 1 (CHK1) inhibition as
a promising therapeutic strategy for selectively targeting SF3B1-mutant HSCs. We propose to build on these
preliminary studies as follows: Aim 1, Define the molecular consequences of SF3B1 mutations on RNA splicing
in human HSCs and progenitors; Aim 2, Define the functional basis of clonal expansion and aberrant
differentiation of SF3B1-mutated HSCs; Aim 3, Identify therapeutic vulnerabilities and preclinical efficacy created
by coordinated mis-splicing of mitotic regulators. The significance of these studies is that they will directly
connect RNA mis-splicing to HSC dysfunction and pathology in MDS. The health relevance is that the proposed
work will directly test novel treatments for MDS with SF3B1 mutations.

Public health relevance
NARRATIVE Myelodysplastic syndromes (MDS) are disorders of the blood system in which patients have insufficient blood production. The SF3B1 gene, which encodes an important RNA splicing factor, is mutated in many patients with MDS. Here, we propose to study how these common mutations in SF3B1 alter the normal function of hematopoietic stem cells and ultimately give rise to MDS, with a long-term goal of developing new treatments.